Selective Control of Synaptically-Connected Circuit Elements by Interluminescence - Diversity Supplement SILVAGNOLI

PROJECT SUMMARY/ABSTRACT
The Diversity Supplement candidate will be trained in all aspects of validating Interluminescence in vivo, from
stereotaxic injections of AAV, verifying construct expression through fluorescence microscopy, to acute
extracellular recordings and computational sophisticated electrophysiological analysis. The experimental
approach will allow the candidate to assess Interluminescence within a well-defined experimental model while
building a solid conceptual and experimental foundation for his graduate work.
The training experiences the candidate will gain are critical for his understanding, designing, and interpretation
of state-of-the-art neuroscience experiments. The training plan takes into consideration that the candidate is at
the beginning of his graduate training, gives him a ‘hot start’ in his education, and ensures that the candidate will
have an exceedingly strong background for meeting his career goals. His training will have ranged from hands-
on experience in designing and executing in vivo experiments for controlling neural activity and behavior to
evaluating and interpreting the collected data. Therefore, this training in in vivo electrophysiology will not only
significantly contribute to the parent grant but will specifically provide him the experience required to pursue his
long-term interest in synaptic plasticity and behavior.
The proposed training outlined in the application is ideal given the candidate’s early career stage and is tailored
to having the greatest impact at the earliest possible time point. An established team training strategy between
the two mentors will foster the candidate’s ability to swiftly reach a level where he can independently investigate
the role of synaptically-connected circuits.
The proposed supplement activities will increase the parent award’s overall impact within the original scope of
award while at the same time advancing the training and career development of the candidate.

Public health relevance
PROJECT NARRATIVE The proposed research is relevant to public health because development and validation of new technologies for selective control of synaptically-connected circuit elements across the brain during behavior is an essential next step to figuring out how they work, and how they fail in disease. Such methods are not available currently and are required to define novel brain circuits and therapeutic strategies for treating devastating neurological and psychiatric disorders, such as depression, autism, schizophrenia, memory decline, addiction, and epilepsy. The proposed research is relevant to NIH’s mission in directly addressing the call for innovating and validating novel tools to facilitate the detailed analysis of complex circuits and enable circuit manipulation (BRAIN Initiative).